SurvivorCare: A digital health solution to support long-term cancer survivorship using patient navigation

Project Summary
There is a growing and urgent need to address a gap in transitional and follow-up care for long-term cancer
survivors shifting from oncology-based to primary and community-based care. Frontline health workers such as
patient navigators and community health workers can support cancer survivors with the transition from oncology-
based to primary care. The overall goal of this Phase II SBIR project is to refine and test SurvivorCare, a mobile-
/web-based system to support long-term cancer survivorship through patient navigation for low-resource,
underserved populations. Following a human-centered design approach and recommendations and learnings
from Phase I pilot work, we will develop and test a functional web/mobile application expressly designed for
patient navigators and other frontline health workers assisting with patient navigation and cancer survivors
through a centralized platform supporting needs related to cancer survivorship care planning. We will achieve
our project goal through 3 specific aims:
• Specific Aim 1. We will build a functional prototype based on feedback collected in Phase I. Specifically,
we will expand the scope of our Phase I work to include support for patients in early stages of survivorship
with prevalent cancer types with survivorship care plans and/or patient navigation programs such as
colorectal, breast, prostate, lung, and head/neck cancers.
● Specific Aim 2. We will conduct usability testing of a functional prototype with target end users (patient
navigators and cancer survivors) to validate content and usability.
● Specific Aim 3. We will conduct beta testing in real-world clinical settings with target end users in two
large, urban, safety net hospitals serving diverse, low-resource populations.
Results from this project will go towards furthering research and implementation efforts in developing tools to
promote collaboration and coordination between frontline health workers, cancer survivors, PCPs, and other
cancer care team members to mitigate pronounced health disparities in long-term cancer survivorship.

Public health relevance
Project Narrative Cancer survivors from low-resourced, minority settings face greater barriers to adherence to survivorship guidelines including communication difficulties, discrimination, and insurance coverage. Patient navigation improves access to care. In this Phase II SBIR project, we will build and test a functional prototype of a mobile/web application, SurvivorCare, in two large, urban hospitals and will assess the prototype with patient navigators and low-resourced, minority patients with cancer types with relatively higher rates of survivorship and patient navigation support such as colorectal, breast, prostate, and lung cancers.